IMAGE RECONSTRUCTION OF ICOSAHEDRAL PARTICLES (MPSA)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Though EMAN has been used successfully for icosahedral and asymmetric reconstruction of virus particles, the EMAN method of particle orientation refinement is a very CPU intensive process for large virus particles. One million CPU hours were consumed to determine the 4.5 [unreadable] map of the epsilon15 phage using the NSF supported TeraGrid computing facility . A similar structure determination using the clusters available at the NCMI combined with outside supercomputer allocations has taken over 12 months to refine a single structure of P22 phage from ~23,000 particle images. We, therefore, look for alternative methods for such large objects, with the same accuracy but a higher CPU efficiency.